Investigating evolutionary antagonism between tumors and lymphocytes

PROJECT SUMMARY
Metastasis accounts for the majority of cancer patient deaths and even though immune checkpoint blockade
has proven effective in many malignancies, metastatic disease remains resistant to therapy. Cancer
metastasis is an inefﬁcient process, requiring cancer cells to disseminate from primary tumors to distant sites,
surviving the stress of migration and evading clearance by circulating immune cells. As a result, metastasis is a
selective event, leading to the establishment of metastatic tumors that often consist of just a few clones. Unlike
the diverse primary tumor from which they derived, these clones must be capable of adapting to new tissue
environments and evading continuous immune surveillance. We hypothesize that even amidst clonal selection
during cancer metastasis, cells acquire diverse phenotypes upon subsequent outgrowth that allows them to
adapt to their environment and evade innate and adaptive immune responses. Utilizing our family of lymph
node metastatic cell lines, we will perform analyses of clonal diversity by viral integration site mapping, proﬁling
diversity across nine rounds of in vivo selection. We will further perform single cell transcriptomics, allowing the
diversity of phenotypes to be uncovered in relation to the clonal composition of each cell line. Expanding these
analyses, we will perform analogous experiments using human head and neck squamous cell carcinoma
specimens, validating whether amidst low genomic clonality tumors can support diverse phenotypic fates. As
we have described previously, metastasis to lymph nodes can induce immune tolerance that permits further
dissemination of cancer cells. We further hypothesize that these diverse phenotypes of metastatic cells drive
unique lymphocyte phenotypes and clonal responses, such that the two antagonize one another. To address
this hypothesis, we will perform phenotypic and immune repertoire diversity proﬁling by spectral ﬂow cytometry
and single cell genomics of murine tumors of varying clonality and the patient tumors already assessed for
clonality and phenotype. The resulting relationship between tumor clonality, T cell phenotype, and T cell clonal
diversity will address whether tumors and lymphocytes evolve antagonistically, adopting varied fates and clonal
architectures in an attempt to outcompete the other side. We will ﬁnally perform similar immune analyses of a
metastatic cell line evolved in the absence of lymphocyte pressure, validating whether ongoing coevolution of
tumors and lymphocytes is occurring during cancer metastasis. These experiments will address the
mechanisms of antagonism and adaption at the tumor-immune interface during cancer metastasis and identify
potential avenues of therapeutic intervention to enhance immune responses against metastasis, such as
delivery of vaccines containing diverse antigens to increase lymphocyte diversity.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to investigate the relationship between clonotypic/phenotypic diversity between tumors and lymphocytes in the context of cancer metastasis. We will evaluate mechanisms of clonal and phenotypic selection and diversiﬁcation of tumors and lymphocytes, identifying evolutionary mechanisms utilized by either compartment to evade or overcome the other. The resulting insights into coevolution of tumors and the immune system will provide an integrative model of tumor evolution and immune dysfunction during metastasis, informing the development of therapies that target these evasion mechanisms, such as by enhancing the diversity of the lymphocyte compartment to overcome limited diversity.